MESA Family - Ocular Component

Recruitment of African American and Hispanic sibships for MESA Family began in May 2004. By the end of 2006, when enrolled was complete, 3026 shipships from 608 families were enrolled. [unreadable] [unreadable] On this MESA Family sample, phenotype annotation is complete and genotyping results are now available. Analytic work is on-going. [unreadable] [unreadable] Genetic analyses on MESA index cases (from the original MESA cohort) are underway using both candidate-wide association strategies (CWAS) and genome-wide association strategies (GWAS).[unreadable] [unreadable] For additional information about the MESA study and projects ancillary to it such as MESA Family, including a list of collaborators and participating institutions, see http://www.mesa-nhlbi.org.